GLYCEMIC INDEX OF MIXED MEALS

The glycemic response to food (glycemic index) has been utilized in diabetic diets in the past but this can be altered by other foods consumed during a meal. The investigators will examine the inter and intra- individual variability of the glycemic index of mixed meals in both diabetic and non-diabetic individuals. These results will allow diabetics to improve glycemic control by arranging daily menus using standard meals with established glycemic responses.